High resolution lineage tracing of developmental hematopoiesis

Project Summary/Abstract:
Investigating the origin of cell types is key to understanding basic processes in developmental biology and to
enable in vitro production of cells and tissues for therapeutic benefit. While major advances in our understanding
the ontogeny of hematopoietic cells have been made, significant technical limitations have precluded us from
having a full picture of the lineage relationships of blood cells during development. For instance, the prevailing
view in the field is that hematopoietic stem cells (HSCs) that emerge in the embryo are the cells responsible for
lifelong blood production in the mammal. However, limited data exist that analyse the long-term fate of the earliest
hematopoietic progenitors entirely in situ. Furthermore, the field still lacks a conclusive understanding of the true
anatomical site of origin of the cells that will become the lifelong HSCs/progenitors in the adult. The Camargo
and Hormoz laboratories have pioneered the use of in situ mammalian barcoding strategies to perform lineage
tracing at the single cell level. Our proposal here aims to utilize these systems investigate the developmental
origins of hematopoiesis. Our application is based on our identification of a population of non-transplantable
embryonic multipotent progenitors (eMPPs) that contribute long-term to post-natal hematopoiesis.
These findings imply that progenitor populations in addition to traditional HSCs have an active and substantial
contribution to adult multilineage blood production. Our first goal in this application is to further characterize
eMPPs molecularly and functionally. We will also explore the idea that functional differences in hematopoietic
lineages can arise based on their eMPP or HSC ontogeny. Finally, we will extend the use of our barcoding
approaches to broadly and unbiasedly characterize developmental waves of blood production and their exact
site of origin. Our work has the potential to uncover basic mechanisms of blood development that could be useful
for therapeutic manipulation.

Public health relevance
Project Narrative: Effective treatment for hematological malignancies and blood cancers remains an outstanding open problem. The only existing cure for most blood disorders is bone marrow transplant, which is only feasible for a minority of patients and has poor prognosis. The work proposed here will provide fundamental new insights into the process of birth of blood forming stem cells, which will help with the production and manipulation of these cells.